The Road from Independence to Parasitism

Project Summary:
Chromera velia is a photosynthetic, free-living algae that is closely related to apicomplexans, which are a
phylum of intracellular parasites responsible for many devastating diseases, including malaria,
cryptosporidiosis, and toxoplasmosis. With molecular and cellular landmarks that are clearly related to but
distinguishable from those found in apicomplexan parasites, Chromera provides a fantastic opportunity to
investigate the evolutionary origin of structures and processes integral to intracellular parasitism. However,
tools for defining localization and functions of gene products do not exist for Chromera, which creates a major
bottleneck for exploring its biology. We propose to overcome these hurdles. Specifically, we will establish a
molecular map of the subcellular structures in Chromera, focusing on identifying structures related to those
known to be important for apicomplexan infection of host cells (Aim 1). In parallel, we will develop
transformation tools that will enable function analysis in Chromera (Aim 2). Our work will yield fundamental
insights into the evolution of aspects of cellular physiology essential for the intracellular parasitic life-style of the
apicomplexans. It will also develop for the community molecular genetic and cell biology tools that will
synergize evolutionary cell biology research for apicomplexans.

Public health relevance
Project Narrative: Chromera velia is a free-living, photosynthetic algae, but it is closely related to the apicomplexans, a large group of intracellular parasites that cause many devastating diseases. Despite the major difference in life-style, Chromera shares many molecular and cellular features with the apicomplexans, providing a fantastic opportunity to investigate the evolutionary origin of structures and processes integral to intracellular parasitism. Our proposed research will yield insights into the evolution of the intracellular parasitic life-style of the apicomplexans, as well as develop molecular genetic and cell biology tools for the community that will synergize the evolutionary cell biology research for apicomplexans.